Mechanisms of Formation and Persistence of Active HIV Reservoirs

ABSTRACT We propose to address several important questions relevant to achieving a functional cure of HIV infection in individuals on suppressive antiretroviral therapy (ART). Specifically, we will examine the timing and mechanisms that establish the active or infectious reservoirs in primary human immunodeficiency virus type 1 (HIV-1) infection; identify the mechanisms by which active HIV reservoirs persist for many years under ART, identify the cells that harbor active reservoirs, and; discern whether reservoirs in individuals initiating ART during primary infection persist in antigen-specific cells and are thus amenable to activation with their target antigens for destruction strategies. Our subject population derives from a unique and long standing cohort of individuals enrolled while in the first few days to months of HIV infection, who went onto suppressive ART prior to 4 months from the date of infection and have had intensive specimen collection during follow-up for up to ~14 years. One hundred and one subjects who initiated ART in Fiebig stages I-V, and remained on ART and virologically suppressed for at least 2 years, form the primary set of subjects for study. Specimens from 4 additional subjects who started ART in chronic HIV infection and experienced a viral rebound when ART was interrupted will be also be used to address one of our questions. We will quantify virus in plasma RNA, as total viral DNA and as 2LTR circular unintegrated viral DNA in peripheral blood mononuclear cells (PBMC), and examine the infectious capacity of proviral DNA in resting CD4+T cells. We will also determine the contribution of proliferating HIV-infected cells, and the relationship between disruption of cellular genes regulating the cell cycle by HIV integration into the chromosome, to the persistence of active reservoirs in blood and in specific subpopulations in PBMC, bronchioalveolar lavage fluids and biopsies of gut-associated lymphoid tissues. Additionally, we will determine whether the putative reservoirs we identify allow HIV to remain active by virtue of inadequate intracellular levels of antiretroviral drugs. Our specific aims are to determine: 1) The mechanisms and kinetics of establishment of active HIV reservoirs; 2) the relative contributions of (A) proliferating HIV- infected cells, and (B) low-level viral replication to the persistence of active reservoirs during ART, and; 3) the proportion of HIV reservoir cells composed of virus-specific CD4+T cells.

Public health relevance
PROJECT NARRATIVE Potential societal benefits from the proposed research include increased understanding of HIV reservoir establishment, how these reservoirs are impacted by early antiretroviral treatment, and possibly information that could help develop strategies for eradicating these reservoirs. This knowledge may lead to an improved understanding on how to accomplish a functional cure for HIV infection. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS: Finding, quantitating, functionally characterizing and ultimately eliminating the infectious viral reservoirs that persist despite antiretroviral therapy (ART) are critical to achieving a functional cure of HIV infection. Recently, several adults and an infant who initiated antiretroviral therapy during primary HIV infection appear to have cleared infectious virus. Why these individuals escaped chronic infection is unclear, but these cases suggest that events occur within the first several weeks of infection that allow HIV to be established in long-lived active or infectious virus reservoirs. With the ultimate goal of enabling cure therapies, we will use specimens from the Seattle Primary Infection Cohort (PIC) to determine the timing and mechanisms that allow HIV reservoirs to form, and to define the cellular sites and antigenic specificity of cells harboring infectious HIV. Aim 1: Determine the timeframe of establishment of active HIV reservoirs. Significance: ART initiated during primary infection may prevent establishment of long-lived infectious HIV reservoirs and lead to "a functional cure" (FC). Defining whether the interval between infection and starting ART is critical to attaining FC, to patient care, and to the public health approach to the HIV pandemic. Hypotheses: 1) Total HIV DNA levels after suppressive ART correlate with the interval between acquisition of HIV and initiation of ART. 2) Decay rates of both total and 2LTR pre-ART HIV DNA will be associated with earlier initiation of ART, whereas a lack of decay correlates with the continuing presence of 2LTR DNA and the presence of active HIV reservoirs. 3) Decay of both total and 2LTR DNA will be associated with very low levels or an absence of infectious proviral DNA, as persisting HIV DNA is primarily defective. Methods: Plasma HIV RNA, total HIV DNA and 2LTR DNA in PBMC will be quantified over >24 months of ART-suppression using banked specimens from subjects starting ART in Fiebig stages I-V (n=101) (Early treatment group, ETG). We will compare time-of-infection to initiation of ART versus concentrations of and changes in viral RNA, and total and 2LTR DNA at pre-ART (0 months), 12 and 24 months, using correlation and regression methods appropriate for the distributions of the data being analyzed. We will also assess these viral species in 4 subjects starting ART in chronic infection and during virus rebound after ART was discontinued (Late treatment group, LTG). Lastly, we will quantitate infectious proviral DNA in ETG (n=14). Aim 2: Determine the relative contributions of (A) proliferating HIV-infected cells, and (B) low-level viral replication to the persistence of active reservoirs during ART. Significance: Recent reports of FC in subjects treated with ART very early in infection suggest that long-lived active reservoirs do not always become established in the first weeks of infection. We have demonstrated that proviruses persist by proliferation of infected cells, and others have shown that these cells contain active virus. In addition, multiple reports have shown low-levels of viral production during ART. Understanding the mechanisms by which active infection is established and maintained will inform FC strategies. Hypotheses: (5) HIV integration interferes with programmed cell-death of infected cells, leading to prolonged cell proliferation and HIV persistence. (6) HIV-infected cells proliferate and release infectious virions that fuel replication during and following interruption of ART. (7) Tissues, cells and/or compartments with ARV levels below effective concentrations provide a sanctuary for continuing low-level HIV replication. Methods: SubAim A: The sequence of provirus integration sites in PBMC from subjects with and without 2LTR DNA (n=18), will be determined and integration-site-specific PCR probes will be used to determine the distribution of proliferating HIV-infected cells in CD4+ subsets from PBMC, bronchoalvealor lavage fluid (BALF) and colonic biopsies (GI), including myeloid, and central and transitional memory T cells. SubAim B: ARV levels will be determined in PBMC, and purified cellular subsets from PBMC, BALF and GI. Aim 3: Determine the proportion of HIV reservoir cells composed of virus-specific CD4+T cells. Significance: Initiation of ART during acute HIV infection may limit the active reservoir to HIV-specific CD4+T cells. If so, stimulation with an HIV vaccine combined with a toxin that targets activated cells could eliminate the reservoir. As anti-HSV, CMV, and EBV immunity is critical to suppressing these chronic infections, these antigen-specific CD4+ cells may also constitute an HIV reservoir that can be activated specifically. Hypothesis: (7) During acute HIV infection the majority of activated CD4+T cells will target HIV proteins or proteins from other chronic viral co-infections, allowing infection of these cells. Individuals starting ART during acute infection will have the majority of their reservoir in HIV-specific or other virus-specific CD4+ cells. Methods: Expose PBMC ex vivo to HIV, CMV, HSV, EBV vs. tetanus antigens (singly and together), flow sort activated and non-activated CD4+T cells and determine ARV levels, viral DNA and 2LTR DNA burden and HIV env sequences to link back to proliferating infected cells.